PUI RESEARCH-ALCORN-MCGEE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The primary focus of this subproject will be to assist the outreach director. The main emphasis will involve recruiting students for the REO program, and visiting labs that have the ability to serve as REO host labs. We also plan to build and maintain a data of student activities and input.